Quantitative assessment of autologous fat grafting in breast cancer treatment using 3D imaging

Project Abstract
Autologous fat grafting (AFG) is a procedure whereby adipose tissue is processed and transferred from
one part of the body to another to add volume and address contour irregularity in soft tissue reconstruction.
Anecdotally, we see improvement in tissue fibrosis and pain with standard grafting after radiation treatment
indicating more than just a volume benefit of AFG. We have recently discovered that the transferred fat or
adipose brings in healthy progenitor cells, growth factors and immune cells helpful in tissue regeneration and
repair. Thus, purified graft is effectively a biological scaffold which can be modified to direct tissue healing or
targeted therapies. One of the hurdles to clinical translation is the variability in graft retention and our ability
to follow the graft over time. The long-term goal of our research is to investigate the capacity of engineered
adipose grafts to improve clinical outcomes by mitigating inflammation and promoting graft retention. We
propose a feasibility study investigating a novel imaging platform to quantitatively assess the overall volume
and three-dimensional (3D) shape of the breast after fat grafting in cancer treatment.

Public health relevance
Project Narrative Breast reconstruction is becoming an area where reconstructive surgery intersects with regenerative medicine as autologous fat grafting is rapidly evolving to include engineered tissue grafts. However, the tools to quantitatively follow these tissues over time is limited by cost, convenience, consistency and clinical applicability, particularly during the engraftment process. The purpose of this multi-disciplinary mixed methods approach is to develop a novel 3D imaging framework to assess volume and surface characteristics in oncologic breast reconstruction with autologous fat grafting and demonstrate feasibility in an outpatient clinical setting.